Wake Forest Atrium HeartShare Clinical Center

Project Summary
Heart Failure with Preserved Ejection Fraction (HFpEF) is the most common form of HF in the US and is
associated with high morbidity and mortality. However, its pathophysiology is incompletely understood, and
most trials have been neutral such that few evidence-based treatments exist. In response, NIH convened 2
workshops co-led by Dr. Kitzman (PI). The highest priority research recommendation was a coordinated effort
to create a large cohort of HFpEF patients and controls and perform comprehensive, deep phenotyping. This
became the basis for HeartShare, whose ultimate goals are to discover novel HFpEF mechanisms, subtypes,
and therapeutic targets. Our Wake Forest - Atrium HFpEF team is highly qualified to serve as a Clinical Center
and make robust, over-arching contributions to HeartShare. Dr. Kitzman is internationally recognized as a
thought-leader in HFpEF with a sustained track record of developing novel concepts regarding HFpEF
pathogenesis, mechanisms, and outcomes and designing and conducting innovative studies to test them. His
team has extensive experience in all key aspects of the HeartShare program, particularly in recruiting,
retaining, and phenotyping diverse populations of HFpEF patients and controls, often significantly exceeding
goals for racial and gender diversity. Our institutions have ~15,000 HFpEF clinical visits annually. In all, our
team has led or helped lead recruitment and phenotyping for 69 studies, mostly NIH-sponsored, with 15,354
participants, demonstrating our ability to fulfill HeartShare recruitment and phenotyping goals. Data from these
studies will be contributed to the Cohort phase of HeartShare. We will make robust contributions to HeartShare
by achieving 4 Specific Aims: Aim 1) Provide ‘thought leadership’ in collaboration with the HeartShare Steering
Committee; Aim 2) Contribute data, images, and stored specimens cohort phase of HeartShare from our
numerous studies of HFpEF and controls, and identify and phenotype HFpEF patients and controls from the
electronic health record using robust bioinformatics tools; Aim 3) Recruit, consent, enroll and follow at least
250 HFpEF patients plus controls (type and number to be determined by consensus); Aim 4) Conduct state-of-
the-art deep phenotyping exams using a collaboratively determined protocol. Our phenotyping proposal is
highly innovative, with advanced echo-Doppler and cardiac magnetic resonance imaging, CPET, physical
activity monitoring, remote and artificial intelligence electrocardiography, sampling of skeletal muscle, adipose,
blood, and microbiome, and mitochondrial energetics, and brain structure/function. Our diverse, cross-
disciplinary team has the full range of complementary expertise and access to the robust resources of two
large, closely affiliated health systems to ensure fulfillment of all HeartShare’s goals. We will help accelerate
and optimize the program’s success with our insight, creativity, and sustained track record of collaboration,
innovation, and dissemination.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) is common, its mechanisms are not well understood, and there are few proven treatments; this problem will be addressed by HeartShare. Our Wake Forest Atrium HeartShare Clinical Center will contribute thought leadership and data from our existing cohorts and trials, and deeply phenotype HFpEF patients plus control participants according to a comprehensive state-of-the art protocol designed to understand cardiac, vascular, and extra-cardiac factors contributing to HFpEF.